Penn TMC: Coordination Core

The Coordination Core’s goal is to manage and coordinate all activities of the Penn Center for Multi-
Scale Molecular Mapping of the Female Reproductive System. The Center’s goal is to create a multi-
modal, multi-scale molecular characterization of ~700 different samples of the human female
reproductive system. We will coordinate the activities of the Penn Center for Multi-Scale Molecular
Mapping of the Female Reproductive System. We will create a management structure with a leadership
group of the MPIs and a Project Manager and four Functional Groups, each led by an expert investigator.
We will create a single workstream with the four functional groups: (1) Clinical Sampling Group; (2) 3D
Modeling Group; (3) Molecular Assay Group; and (4) Data Coordination Group. We will use electronic
work systems for communication and project management. Detailed monthly production goals will be
established and managed by the MPIs and the project manager. In addition, we will coordinate activities
of the Penn Center with the HuBMAP consortium groups. The Coordination Core will manage all
interactions with the HuBMAP consortium, NIH Program Staff, and other outside entities. We will
participate in all meetings, conference calls, and coordination events. We will work with other TMCs to
collaborate in establishing robust protocols and adopting the assays deployed by other centers. We will
coordinate with the HIVE groups to deposit and disseminate the data, as well as to develop a common
3D anatomical model and coordinate framework for the female reproductive system. The activities of the
Coordination Core will ensure efficient operations of the Penn Center and help meet the milestones of
our public resource generation project.